FAT FREE MASS DURING LOW CALORIE DIET IN OBESE PTS OF DIFFERENT BODY COMPOSITION

Difference, if any, in protein loss and fat free mass loss between moderate obese and severely obese subjects when they are on the same calorie restric on.